Associations of Adverse Childhood Experiences with Midlife Neighborhood Deprivation and Cognitive Trajectories and Dementia Outcomes in Later Life

Project Summary
The burden of Alzheimer’s Disease and Related Dementias (ADRD) is projected to increase by 150% by the year 2060 to
affect 14 million Americans, with four- and seven-fold increases anticipated among Black and Hispanic/Latino older
adults. To better understand the accumulation of risk throughout the life course and the disparities that exist in ADRD,
studying social and structural determinants of health and employing a life course perspective have been emphasized.
Research on the role of early life stressors and adversity on ADRD is emerging, but still limited. Older adults who
experienced more childhood adversities had greater likelihood of incident dementia in three international aging cohorts;
U.S.-based studies have been largely cross-sectional in design, mixed results have been observed, and only one
examined racial/ethnic differences. However, greater understanding of the role these factors play is imperative if we
aim to mitigate the risk of ADRD with a health equity lens. Identifying early life risk factors for ADRD and the primary
pathways through which childhood adversity is operating will allow for more targeted interventions to reduce risk of
ADRD in later life for the most vulnerable in our population.
In addition, the role of neighborhood deprivation in these relationships remains understudied, despite known
ramifications of environmental factors on health behaviors and outcomes. Understanding structural determinants of
health and how they impact risk of ADRD will provide valuable insight for identifying the most vulnerable communities
for targeting effective prevention strategies and motive for structural changes and policies that aim to improve these
environments and the overall health of those individuals at greatest risk. To have the greatest impact on reducing the
risk of ADRD, the role of the environment must be considered.
In the F99-phase of this proposed research, Adrienne Lee will conduct three novel studies of these complex associations.
Specifically, Adrienne will use the Health and Retirement Study to evaluate the associations of childhood adversity with
neighborhood deprivation, cognitive trajectories, and dementia outcomes within racial/ethnic subgroups. She will link
the study sample to the area deprivation index in midlife to further understand the role of environment and structural
determinants of health on these associations, and to identify population-specific mechanisms by which we can tailor
interventions throughout the life course.
In the K00-phase of this proposed research, Adrienne will build off her dissertation research to identify early life
resilience factors that promote healthy cognitive aging and that may counteract ACE exposure, and she will examine the
associations of ACE exposure, in combination with neighborhood deprivation in relation to other hallmarks of aging. This
research will inform equitable interventions.

Public health relevance
Project Narrative Risk of Alzheimer’s Disease and Related Dementias (ADRD) accumulates throughout the life course and disproportionately burdens older Black and Hispanic/Latinx adults in the U.S. Understanding the role that adverse childhood experiences and neighborhood deprivation play in ADRD risk overall and within racial/ethnic subgroups may elucidate root causes of the disparities observed among older American adults and motivate tailored, culturally sensitive strategies and structural reform to reduce risk. This research proposal will develop and link measures to a large diverse longitudinal aging cohort and apply a life course perspective from childhood to midlife to older age to better understand social and structural determinants of health and cognitive outcomes in U.S. adults and within racial/ethnic groups.